New Mexico Clinical Trials Node: Clinical research and practice to address substance use in diverse, rural and underserved populations

ABSTRACT
NM is an epicenter of the opioid crisis in the US, with one of the highest overdose mortality rates since 1990.
Both heroin-attributable opioid deaths and deaths from prescription opioids have increased, especially in
Hispanic and American Indian/Alaska Native groups. Many challenging social determinants, including poverty
and unemployment contribute to high rates of OUD in NM. Our group is ideally suited to lead a NIDA CTN
Node because of the breadth and depth of our involvement in OUD research, extensive clinical trials
experience, intimate connection with the ECHO Institute and its use for expanding access to SUD treatments,
links with AI/AN researchers and clinicians, our proven ability to recruit diverse rural populations to participate
in research, as well as informatics and data science capacity. The Aims of the NM Node are to: 1) develop
and maintain a highly efficient platform to conduct clinical trials that will inform evidence-based prevention and
treatment of OUD; 2) collaborate on and lead research that addresses and improves outcomes across the
OUD Cascade of Care (CoC); 3) promote uptake of best-practices in OUD prevention and care in NM and
nationwide through effective dissemination of evidence-based innovations. The expected impacts will be
expanded research in diverse, rural and underserved populations impacted by the opioid crisis, and increased
capacity of providers and researchers to collaborate on, lead, and propose impactful research. NM Node
research will ensure the development of robust and generalizable methods for prevention, identification, and
treatment of OUD including evaluation and modification of the CoC expanding the local and national
knowledge base. Our dissemination aim will ensure a productive cycle of engagement and translation of
evidence-based practices and promote a sustained positive impact on the OUD CoC in communities in NM
and nationwide. Our proposal builds on multiple assets: 1) a strong alliance with the primary care health
providers in (i) an existing PBRN (RIOS Net) that extends into rural NM, (ii) UNM community-based primary
care clinics; (iii) and providers of SUD/ and OUD treatment at multiple rural and urban sites across NM
including over 400 that have engaged with ECHO learning networks; 2) 15 years of prior CTN and protocol
management experience; 3) expertise conducting research including clinical trials with patients with SUD and
OUD; 4) leadership in health services including Project ECHO, informatics, and implementation research; 5)
access to unique and diverse communities and patient populations, including medically underserved, rural,
Hispanic and American Indian; 6) strong clinical and educational expertise in MOUD and 7) our strength in
behavioral interventions for SUD, centered in CASAA .

Public health relevance
PROJECT NARRATIVE The New Mexico Node will leverage the strong research alliance that has been forged between University of New Mexico researchers and providers of clinical care across the state, working in primary care, behavioral health, maternal/child health, adolescent, public health, and criminal justice settings. By extending the reach of the NIDA CTN to the “majority minority” population of NM, we will play an integral role in establishing best practices for treatment of OUD/SUDs in uniquely diverse, rural populations. Our team’s extensive SUD/OUD expertise in implementation of clinical trials, behavioral health interventions informatics, workforce development, education/knowledge dissemination, and harm reduction will allow us to make an outsized contribution to improvement of public health via prevention and treatment of OUD.